Oncology-focused Postdoctoral Training in Care Delivery and Symptom Science (OPTICS)

The Oncology-focused Postdoctoral Training In Care Delivery and Symptom Science (OPTICS) T32 program will mentor and train physicians and scientists with PhDs in social or quantitative sciences to conduct research focused on innovative cancer are delivery that narrows the gap between outcomes that are possible based on contemporary scientific understanding of cancer prevention and treatment and outcomes that are actually achieved. This persistent gap results in a critical need for translational researchers who are focused on risk reduction, symptom science, and innovative care delivery and have rigorous training in research methods required for care delivery transformation and leadership of health system–level interventions to improve treatment outcomes. The cornerstone of the OPTICS program will be a 2-year mentored research experience in which trainees will conduct research aligned with one or more of four thematic areas: 1) Data Science, 2) Risk Mitigation, 3) Symptom Science, and 4) Care Delivery. OPTICS trainees will receive 1) intensive mentorship and the resources necessary to execute a focused research project in one or more of the thematic areas; 2) training in core methods necessary for impactful research through coursework, seminars, workshops, and reading groups; and 3) training in skills required for career building, including protocol development and execution, management, grant writing, team building, patient engagement, dry-laboratory organization, and the responsible conduct of research. OPTICS will be co-led by 2 PhDs and 2 MDs at Memorial Sloan Kettering Cancer Center (MSK) with long track records of impactful research, mentorship, and successful knowledge translation. This structure will afford participants methods training and the ability to launch interventions in the community and the clinic. OPTICS will train 6 postdoctoral fellows each year (3 new appointees and 3 re-appointees) with a team of 36 core program faculty, 10 emerging mentors, and 6 research supporters with relevant supporting skills, expertise, and resources. Required core program training at the New York City campus of MSK and its partner Weill Cornell Medical College is supplemented by an array of elective learning opportunities customized to each trainee’s needs and learning style. Trainees will obtain the skills necessary to develop, test, and implement new approaches to optimizing patients’ experiences by focusing on risk reduction, symptom control, communication, and new models of cancer care delivery. These skills are crucial to address the challenges brought about by the tremendous growth in the complexity and chronicity of cancer care. OPTICS aims to prepare trainees for impactful careers focused on innovations to optimize cancer care quality and translation of knowledge to ensure that discoveries made in the laboratory and clinic realize their full impact on population health and well-being.

Public health relevance
The Oncology-focused Postdoctoral Training In Care Delivery and Symptom Science (OPTICS) T32 program will train postdoctoral fellows (MDs and PhDs) to conduct innovative translational research to decrease cancer mortality by improving cancer care delivery. The program's cornerstone will be a 2-year mentored research experience in which trainees will I) execute an impactful research project aligned with one or more of four cancer-focused thematic areas: (1) Data Science, (2) Risk Mitigation, (3) Symptom Science, and (4) Care Delivery; II) train in core research methods through coursework, seminars, workshops, and reading groups; and III) acquire the professional skills prerequisite for success as independent investigators. OPTICS trainees will benefit from Memorial Sloan Kettering Cancer Center's large patient population, faculty mentors, data assets, New York City location, and close partnership with Weill Cornell Medicine and Rockefeller University, as well as its vibrant culture dedicated to population health, training, and scientific discovery through collaborative multidisciplinary team science.